Administrative Core

The main goal of the Administrative Core of this Proposal is to facilitate and support the unification and interaction of the scientists and administrative personnel working on the five Projects and three Cores within the four institutions taking part in this Conte Center Proposal. Specific Aims. Aim I. Coordination and communication between the Cores and Projects in the Proposal - Facilitate communication between the five Projects and three Cores - Schedule all formal meetings - Facilitate the transfer of information for data sharing and manuscript generation - Supervise and assist in the design, implementation and maintenance of the Center website - Career development coordination center for students and postdoctoral trainees Aim II. Maintenance of the Physical Working Space, Supplies and Equipment for the Cores and Administrative Center of the Proposal - Maintenance of the physical laboratory and administrative space - Oversight of the laboratory safety guidelines - Purchase of and maintenance of supply stocks Aim III. Data and Progress Record Maintenance and Clerical Support for the Proposal - Clerical support and record maintenance - Maintenance of project-generated resources files - Publication generation and archive for the Proposal

Public health relevance
Relevance to public health: Schizophrenia is a debilitating psychiatric disorder affecting ~1 % of the population. New therapeutic treatments for schizophrenia are needed. The Administrative Core will provide a common point of contact, communication and data collection and storage for the work of this Conte Center Grant.